Multimodal Optical Imaging on the Effect of Maternal Polysubstance Exposure on Fetal Brain Microvessel Function

PROJECT SUMMARY
The etiology of congenital brain growth anomalies is complex, but prenatal alcohol/ethanol and nicotine exposure
(PEE/PNE) are common causal factors in the US and worldwide. Research has mainly focused on the growth
deficits in neural stem cells (NSCs) and their progeny following PEE/PNE. However, we recently used high-
resolution imaging to document that PEE results in complementary deficits in blood flow in major cranially-
directed arteries. During the previous project period, we adapted Optical Coherence Tomography (OCT) to
document that both PEE and PNE resulted in a similar loss of blood flow in the efferent peri-neural vascular
plexus (PNVP). The PNVP and its companion, the sub-ventricular vascular plexus (SVP), give rise to capillaries
that penetrate the parenchyma of the developing brain. In the NSC niche of the fetal ventricular zone (VZ) these
give rise to an atypical class of fenestrated capillaries that contain 50-100 nm-sized trans-endothelial windows.
The function of capillary fenestration in the fetal brain is unknown. Still, in the adult brain, the presence of
fenestrated capillaries in selected circumventricular brain regions facilitates the transfer of systemic
macromolecules into the brain, and persistent activation of brain microglia, and in residual neurogenic niches,
facilitates neurogenesis. Based on preliminary and published data, we hypothesize that prenatal ethanol will
increase brain angiogenesis, capillary fenestration, and microglial immune cell precursor trafficking to the fetal
brain. We further hypothesize that prenatal nicotine will potentiate the alcohol-mediated increase in new blood
vessel formation in the fetal brain and additively increase capillary permeability and immune cell migration into
the NSC niche of the fetal VZ. To test these hypotheses, our team will develop a new sensitive, high-resolution
imaging platform (Aim 1) that combines the complementary benefits of OCT and two-photon light-sheet
microscopy (2pLSM) for in utero time-resolved structural imaging of fetal brain capillary micro-vessels with
molecular specificity. We will also adapt our innovative intravital imaging technology and mouse reporter models
to assess the effects of PEE and/or PNE on the dynamic growth of fetal VZ capillaries and their capacity to
transfer macromolecules from fetal systemic circulation to the brain (Aim 2) and the adhesion and diapedesis of
immune microglial cell precursors into the fetal NSC niche (Aim 3).
This proposal will result in innovative high-resolution imaging tools for in utero fetal imaging and enable for the
first time, dynamic, time-resolved assessment of capillary permeability and monocyte precursor invasion, to fill
a significant gap in our understanding of the genesis of brain growth deficits due to PEE and/or PNE. These
studies will also position us to begin to assess the efficacy of novel pharmacological intervention strategies
targeted to prevent or reverse the effects of PEE and PNE on fetuses

Public health relevance
PROJECT NARRATIVE Prenatal alcohol/ethanol and nicotine exposure (PEE/PNE) are common causal factors in the US and worldwide for fetal brain growth deficits, and their effects can be synergistic. The proposed research is relevant to public health because it provides a new method for understanding the impacts of maternal ethanol and nicotine consumption during pregnancy on the mammalian brain and microvasculature development. The proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will reduce the burdens of human disability, in this case, due to exposure to toxins during gestation.